Novel mechanism of alcohol self-administration and relapse

Project Summary/Abstract
Alzheimer's disease (AD) and its related dementias (AD/ADRD) are a set of irreversible and progressive
neurodegenerative disorders that represent the most common cause of dementia in the United States. Tau-
associated AD/ADRD neural pathology originates in the entorhinal cortex (EC) and spreads to the hippocampus
(HPC) and other connected brain regions as disease severity progresses. Although links between alcohol use
and Tau-associated pathology have been established, the mechanisms that underlie this unique interaction are
not fully understood. In this Administrative Supplement, we propose to address this gap in knowledge by
expanding the parent R01 to evaluate the genomic interaction between chronic alcohol drinking (12-weeks) and
the development and progression of AD/ADRD neural pathology using an innovative AAV strategy for human
Tau-P301L (huTau-P301L) “seeding” in the EC of C57BL/6J mice. We propose to utilize GeoMx Digital Spatial
Profiling (DSP) with quantification by next-generation sequencing (NGS) to evaluate the interaction between
alcohol drinking and huTau-P301L expression on the whole transcriptome (>18,000 genes) from neurons and
glia in the EC, hippocampus, and other connected brain regions. We will also evaluate pathological huTau-P301
expression in the EC, propagation (spread) to the HPC and other nuclei, Tau misfolding, and Tau (AT8)
hyperphosphorylation in a parallel immunohistochemistry study. These separate but integrated studies can be
conducted during a 1-year period of the parent R01. This work is based on strong preliminary data generated
under a prior project showing that alcohol drinking produced an early onset and profound increase in pathological
human Tau-AT8 phosphorylation in the hippocampus that were time-locked with early onset and increased
magnitude of hippocampal-dependent cognitive deficits in 3xTg-AD mice. Given this prominent involvement of
Tau in our prior alcohol studies and its widely acknowledged function as a key mechanism of AD/ADRD, we
predict that the proposed studies have a high probability of identifying a unique transcriptomic footprint of alcohol
that contributes to AD/ADRD pathology. Identifying novel neural targets of alcohol that underlie AD/ADRD
pathology has potential to lead to specific diagnostic and therapeutic strategies.

Public health relevance
Project Narrative The link between alcohol use and Alzheimer’s disease has been widely studied; however, the neurobiological mechanisms that mediate this potential interaction are not fully understood. The overall goal of this application is to test the hypothesis that alcohol exacerbates Tau propagation (spread) and associated pathology in the brain. This work has significant public health implications and potential to identify novel therapeutic strategies to help individuals who fall into a specific class of neurodegenerative disorders involving alcohol use and AD/ADRD pathology.